Protocol Review and Monitoring System

PRMS PROJECT SUMMARY/ABSTRACT
The goal of the Protocol Review and Monitoring System (PRMS) at the Holden Comprehensive Cancer
Center (HCCC) is to ensure the highest scientific quality of clinical oncology research is conducted at
the HCCC. A two-step review process is used. Trial concepts are first reviewed by the disease-specific
Multidisciplinary Oncology Groups (MOGs) to determine enthusiasm for the proposed science, potential
impact of the results and whether the resources and patient population are adequate to complete the
proposed studies. The Trial Resource Evaluation Committee (TREC) provides input into whether the
institutional resources are available to support the trial. Once a protocol is approved by the MOG and
has TREC endorsement, it is fully developed and reviewed by the Protocol Review and Monitoring
Committee (PRMC). The PRMC approves, rejects or defers the protocol for further development.
Studies which have already undergone rigorous peer review including NCI-approved NCTN studies and
studies approved by other NCI-designated cancer centers with an acceptable PRMS, are reviewed
administratively by the PRMC Chair. PRMC approval is required before IRB review. The PRMC also
monitors accrual to ongoing clinical trials. The PRMC closes protocols that do not demonstrate
scientific progress or that are no longer addressing a scientifically valid question.

Public health relevance
PROJECT NARRATIVE Not applicable